Implementation and validation of a lung x-ray interferometry imaging system, with applications to COPD, COVID-19 and other lung diseases

7. Project Summary/Abstract
According to PAR-22-073, this summary/abstract document is not required as a separate
document, but it is included in the Research Strategy section as; Executive Summary and
Project Plan.

Public health relevance
8. Narrative According to PAR-22-073, this narrative document is not required as a separate document, but it is included in the Research Strategy section as; Executive Summary and Project Plan.